DICLOFENAC SODIUM TREATMENT FOR JUVENILE IDIOPATHIC OSTEOPOROSIS

Diclofenac sodium has been shown effective in decreasing the elevated urinary calcium excretion present in adults with idiopathic osteoporosis. We propose to use this same therapy in a 7-year-old female with severe juvenile idiopathis osteoporosis who has failed estrogen therapy.